Dorsal midline patterning in the vertebrate CNS

DESCRIPTION (provided by applicant): The goal of this proposal is to define the general principles of dorsal medial germinal zone organization and regulation, using Lmx1a as a molecular entry point. Dorsal brain germinal zones, such as the cerebellar rhombic lip and telencephalic cortical hem, contribute substantially to neuronal diversity in the CNS, but the mechanisms that drive their neurogenesis are ill-defined. Using genetic fate mapping and mutant analysis we have demonstrated that during cerebellar development, the LIM-homeodomain transcription factor Lmx1a 1) segregates the roof plate lineage from neuronal rhombic lip derivatives, 2) is required for maintenance of the entire late embryonic rhombic lip and 3) confers posterior vermis identity to a subset of rhombic lip cells. These experiments demonstrate that the cerebellar rhombic lip is a heterogeneous progenitor population with fates specified at very early stages, yet we know nearly nothing about the cellular and molecular characteristics of rhombic lip progenitors. In Aim 1 of this proposal we will conduct an extensive analysis of rhombic lip progenitor gene expression and cell cycle parameters in wild-type and Lmx1a-/- animals to characterize the organization, developmental mechanisms and molecular pathways conferring cell fate within the rhombic lip. Using expression microarray analysis of microdissected e13.5 cerebellar rhombic lip from wild-type and Lmx1a-/- animals, we have identified several Lmx1a-candidate effectors and we will characterize their roles in rhombic lip development through analysis of extant mouse mutants and manipulation of gene expression using in utero mouse electroporation. Our preliminary data demonstrate that Lmx1a also regulates neurogenesis in the telencephalic cortical hem, where loss of Lmx1a results in aberrant expression of the cortical selector gene Lhx2, which leads to excessive production of hippocampal cells instead of Cajal-Retzius cells. In Aim 2 we propose a series of genetic fate mapping and in vitro explant analyses to test if Lmx1a acts intrinsically in the cortical hem to regulate cortical hem neurogenesis and if the adjacent telencephalic choroid plexus, where Lmx1a is also expressed, also influences hem development. We will also conduct expression analyses to determine if Lmx1a-downstream effectors are conserved across dorso-medial germinal zones. Finally in Aim 3, we will explore the basis of dorsal midline abnormalities when both Lmx1a and Lmx1b function removed. These basic neurodevelopmental analyses have direct translational relevance to human structural malformations of the CNS and have potential to reveal new insights into the dramatic evolution of cortical size in mammals.

Public health relevance
PUBLIC HEALTH RELEVANCE: With recent advances in imaging and genetics, malformations of the human brain are more frequently recognized. These malformations cause neurodevelopmental and motor delays in affected children, yet we know very little regarding which processes that go awry while the brain is developing or the underlying genetic causes. This grant uses genetic manipulations in the mouse to define the organizational principles of the embryonic stem cell populations that reside on the dorsal midline of the brain and generate vast numbers of neurons in the adult brain responsible for memory and motor coordination. When these stem cell populations develop abnormally, birth defects of the brain including cerebellar and cerebral malformations and hydrocephalus result. An improved understanding of their basic developmental biology will ultimately lead to improved diagnosis and eventually treatment for these devastating brain disorders. Project Narrative With recent advances in imaging and genetics, malformations of the human brain are more frequently recognized. These malformations cause neurodevelopmental and motor delays in affected children, yet we know very little regarding which processes that go awry while the brain is developing or the underlying genetic causes. This grant uses genetic manipulations in the mouse to define the organizational principles of the embryonic stem cell populations that reside on the dorsal midline of the brain and generate vast numbers of neurons in the adult brain responsible for memory and motor coordination. When these stem cell populations develop abnormally, birth defects of the brain including cerebellar and cerebral malformations and hydrocephalus result. An improved understanding of their basic developmental biology will ultimately lead to improved diagnosis and eventually treatment for these devastating brain disorders. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS The cerebellar rhombic lip and telencephalic cortical hem represent two dorsal medial germinal zones of the vertebrate CNS which give rise to a numerous important cellular populations. The cerebellar rhombic lip gives rise to several brainstem nuclei of the pre-cerebellar system, the glutamatergic neurons of the cerebellum including a subset of deep nuclei neurons, and the granule neurons and unipolar brush cells of the cerebellar cortex (1-3). The telencephalic cortical hem is a major source of Cajal Retzius cells (4) and is a transient signaling center required for hippocampal induction (5). In addition to producing the large diversity of neurons, both zones also generate the choroid plexus epithelium - the source of cerebral spinal fluid and a major blood brain barrier (6). Disruption of these zones contributes to hydrocephalus and congenital malformations of the cerebellum and cerebral cortex (7). Despite their importance to basic and clinical neuroscience, little is known about the regulation of the cell fate specification of their derivatives. This is in contrast to CNS ventricular zones which have been extensively studied. The goal of this proposal is to define the general principles of dorsal medial germinal zone organization and regulation. Recently we determined that Lmx1a, a LIM-homeodomain transcription factor, is a major regulator of neurogenesis within dorsal medial germinal zones in the CNS. Our data reveals unexpected early molecular and functional heterogeneity within the cerebellar rhombic lip. We show that Lmx1a is required for the proper production and location of lineages arising from the cerebellar rhombic lip and telencephalic cortical hem. These results provide the first evidence that neurogenesis in these diverse zones share molecular regulatory mechanisms. We propose to use Lmx1a as an entry point to define the molecular and developmental pathways which confer cell fates within the cerebellar rhombic lip and telencephalic cortical hem. AIM 1: Test the hypothesis that Lmx1a identifies and regulates a novel progenitor population(s) in the cerebellar rhombic lip Our preliminary data indicates that Lmx1a is expressed within a subpopulation of cerebellar rhombic lip cells from e12.5. Fate mapping studies indicate that these cells are fated to become granule neurons of the adult posterior cerebellar vermis. Loss of Lmx1a function causes their mislocalization to the anterior cerebellum and premature regression of the rhombic lip. Since Lmx1a is not expressed in granule cell progenitors once they leave the rhombic lip, Lmx1a must confer these properties within the rhombic lip. In the first part of this Aim, we propose to characterize the Lmx1a+ rhombic population in wild-type and Lmx1a-/- animals, to define the nature of these progenitors relative to other known markers and cell cycle parameters to delineate its regulatory role in cell behavior. In the second part of this Aim, we will determine the molecular mechanisms used by Lmx1a to regulate rhombic lip neurogenesis. This will entail confirmation and characterization of candidate (delete-of) Lmx1a-downstream effectors which we have identified from expression microarray analysis. These experiments will examine rhombic lip phenotypes in 4 readily available mouse mutants and will use in utero electroporation of mouse cerebellar anlage to manipulate expression of additional candidate effectors. AIM 2: Test the hypothesis that Lmx1a regulation of neurogenesis is generalizable to other long-lived dorsomedial germinal zones. Case study: the cortical hem We have determined that Lmx1a also regulates neurogenesis in the telencephalic cortical hem, where it directs the production of Cajal-Retzius cells vs. hippocampal neurons. In the first part of this Aim, we will use fate mapping and explant analyses to define the specific role of Lmx1a in the cortical hem from its role in the adjacent developing choroid plexus, where it is also expressed. In the second part, we will define downstream components of the Lmx1a-pathway in cortical hem neurogenesis, using expression microarray analysis of microdissected hem from wild-type and Lmx1a-/- tissue. This analysis will determine the extent to which downstream pathways are conserved across distinct dorsomedial germinal zones. AIM 3: Test the hypothesis that dorsomedial neuroepithelial - mesenchymal interactions are critical for telencephalic dorsal midline patterning and regulate cortical size Loss of Lmx1a-/- causes cell fate abnormalities of the telencephalic cortical hem, but loss of both Lmx1a and Lmx1b causes dramatic specification abnormalities of the hem, choroid plexus and hippocampus, although Lmx1a and Lmx1b are never co-expressed. In addition an unexpected expanded and folded lateral cortex phenotype is evident although the Lmx1 genes are only medially expressed. In the first part of this aim, we will characterize early dorsal medial cell fate specification abnormalities in Lmx1a/b double mutants. In the second part of this Aim, we will characterize the nature of the expanded lateral cortex to determine how fate changes at the dorsal midline can have a major impact on the development of lateral cortex. The dramatic evolution of cortical size in mammals may depend on this signaling pathway.